Spotlight on the Cancer Cell: Intrinsic Properties and Vulnerabilities for Therapeutics

Abstract
Support is requested for a Keystone Symposia conference entitled “Spotlight on the Cancer Cell: Intrinsic
Properties and Vulnerabilities for Therapeutics,” organized by Drs. Anwesha Dey, Laura D. Attardi and Mariam
Jamal-Hanjani, with scientific programming input from Keystone Symposia. The meeting will take place January
26–29, 2026 in Raleigh, North Carolina.
Tumor evolution is a process by which cells acquire genetic and epigenetic alterations that lead to inappropriate
cell proliferation. This process is fueled further by extensive interactions between cancer cells and cells of the
tumor microenvironment, including immune cells and fibroblasts. In recent years, there has been a great deal of
attention focused on the tumor microenvironment and signaling between different cell types within the tumor. A
priority of this Keystone Symposia conference is to draw attention back to the cancer cell itself to think about the
cell intrinsic mechanisms that promote tumor development. This focus will not only provide a deeper
understanding of the underpinnings of carcinogenesis but also provide new insights into potential strategies for
therapeutic interventions. We believe this focus is directly aligned with the NCI’s Division of Cancer Biology’s
priorities to explore basic, fundamental questions in cancer biology, which provides the research foundation that
improves understanding of the disease and may lead to new approaches for prevention, diagnosis, and
treatment. Specifically, conference sessions will cover broad topics ranging from tumor evolution, tumor
heterogeneity, and metabolic rewiring and plasticity to drugging cancer cell-intrinsic pathways and cancer cell
vulnerabilities. There will also be discussions on emerging topics and unanswered questions in the field. As the
goal of the meeting is to stimulate thinking about changes in cancer cells themselves during the process of tumor
evolution, this meeting is distinct from many meetings in the cancer field, which focus much more on crosstalk
between various cell types in the tumor. Attendees will thus take away a broad-based overview of the field that
is uniquely focused on the cancer cell itself, a critical perspective for both understanding tumor evolution and for
designing better cancer therapies.

Public health relevance
Project Narrative Despite substantial progress in cancer treatments, a renewed focus on the biology of the cancer cell will be essential in understanding tumorigenesis and in identifying potential cancer cell vulnerabilities that can be exploited to develop more effective therapeutics, especially for cancers with limited treatment options. This Keystone Symposia meeting, “Spotlight on the Cancer Cell: Intrinsic Properties and Vulnerabilities for Therapeutics,” aims to bridge this gap by focusing on the intrinsic mechanisms within diverse cancer cell types that promote carcinogenesis and by applying this knowledge to identify next-generation diagnostics and therapeutic targets. To achieve this, this conference will bring together basic scientists, academic clinicians and drug developers to discuss the emerging biology of cancer cells and build new cross-disciplinary collaborations to advance new approaches for cancer treatment.